CCR Microscopy Core

The CCR NCI Microscopy Core is used consistently by a wide range of NCI researchers with 154 users from 36 labs in the past year. Among the techniques now in use within our CCR microscopy core are methods to visualize live cells in three dimensions over time, including the tracking of cellular signaling using specialized fluorescent protein reporters, super-resolution imaging of prokaryotic cell division, in vivo imaging of tumor cell growth, super-resolution imaging of chromatin architecture in tumor cells, and monitoring cell cycle activity dynamics in development. For example, our Leica Stellaris 8 FLIM microscope is used to image intact cleared tissue to quantify the lineage of specialized endothelial cells. In addition, because it has fluorescence lifetime imaging capability, it has been used to measure the metabolic changes in tumor cells. The projects supported represents the diversity of cancer research pursued by CCR investigators.